SIP 24-003 Cancer Prevention and Control Research Network (CPCRN) Coordinating & Collaborating Centers at the University of North Carolina at Chapel Hill

PROJECT SUMMARY/ABSTRACT
For more than 20 years, the Cancer Prevention and Control Research Network (CPCRN) has been a national
leader in developing and implementing effective interventions that decrease the burden of cancer in diverse
and medically underserved communities. Since 2004, the University of North Carolina (UNC) has hosted both
the CPCRN Coordinating Center and a Collaborating Center (Comprehensive Cancer Control Collaborative of
North Carolina (4CNC)). 4CNC's work in the last cycle included co-leading 6 work groups, producing 161 peer-
reviewed publications (41 cross-center publications), and completing a successful core project which
subsequently led directly to a multicenter NCI-funded R01. The Coordinating Center's work included
shepherding more than 200 members through a workgroup formation consensus process, supporting
workgroup communication and functioning, sharing resources, and implementing, evaluating the
implementation of the strategic plan of CPCRN, and coordinating the publication of a 21-article supplement in
Cancer Causes & Control featuring 118 unique CPCRN members as authors. UNC as the Coordinating Center
demonstrated our ability to achieve these functions, while maintaining stability during the COVID19 pandemic
and despite significant turnover in network membership between funding cycles. Given our strong history of
supporting collaboration while embracing new members and innovative ideas, we are well prepared to guide
the Network through another transition because of our long history as committed stewards of the CPCRN's
mission, vision, and action plan. The overarching goal of the Network and the UNC Collaborating Center and
Coordinating Center is to reduce the burden of cancer through the development, dissemination, and
implementation of community-engaged, evidence-based interventions. Our specific aims are to: (1) Develop
and pilot test the Pharmacy-Assisted Cessation of Tobacco and Screening (PACTS) intervention to increase
access to lung cancer screening shared decision-making in medically underserved populations through
integration with pharmacy-based tobacco cessation programs. (Collaborating Center); (2) Lead and collaborate
in community-engaged, cross-center projects to improve cancer prevention and control (Collaborating Center);
(3) Facilitate and support collaborative research linkages among Network members, Network Affiliates,
Scholars and national, state, and local community partners to advance the implementation of proven cancer
prevention and control strategies in practice and policy (Coordinating Center); and (4) Evaluate and
disseminate the products and impact of Network activities (Coordinating Center). The expected long-term
impact of this work is the significant reduction in cancer burden and cancer health disparities achieved through
collective network contributions to science, practice and policy that extend beyond what any individual center
could achieve on its own.

Public health relevance
NARRATIVE For more than 20 years, the Cancer Prevention and Control Research Network (CPCRN) has been the national leader in the collaborative development and translation of knowledge to improve cancer prevention and control in medically underserved communities, with investigators at UNC leading the CPCRN Coordinating Center and one of eight Collaborating Centers. We propose to continue to leverage our successful leadership experience, community orientation, inclusive approach to membership and governance, and extensive resources, tools and policies and procedures developed to support network collaboration to advance the goals of the CPCRN and the CDC’s Prevention Research Centers Program. The expected impact of this work on cancer health outcomes and cancer health disparities is significant, given the breadth and depth of cancer prevention and control science generated, the multidisciplinary and community-engaged nature of collaborations, and the focus on pragmatic, scalable, and health equity-focused interventions among members and community collaborators.